ADaPT to Engage: Assessing for Disparities and Potential Targets for Intervention to Engage Acutely Ill Children in Research

PROJECT SUMMARY: Clinical research must enroll individuals from diverse backgrounds to yield
generalizable knowledge and ensure that the benefits and burdens of research are fairly distributed. Under-
representation of diverse groups may: (1) lead to poor enrollment leading to delays and/or study failure, (2)
prevent diverse groups from experiencing the benefits of research and (3) result in investigators missing
important diversity based differences in illness and treatment. The pediatric literature has not produced
consensus regarding under/over enrollment of diverse groups in research and there is inadequate
understanding as to why disparities may exist. Enrollment in emergency and critical care (ECC) settings
presents unique challenges. These factors, coupled with knowledge that health outcomes are strongly tied to
evidence supporting medical interventions, motivate the proposed research. The goal of this proposal is to
characterize research participation by children at risk for health disparities (CRHDs) in pediatric ECC research
and to determine the degree to which modifiable and potentially modifiable factors relate to participation. The
central hypothesis—that CRHDs are underrepresented (losing research benefit) and overrepresented
(risking exploitation) in others and that modifiable factors are the primary drivers of differential study
enrollment—will be evaluated in a mixed-methods study with 3 interrelated but distinct aims: Aim 1: To
prospectively characterize enrollment by CRHDs in pediatric ECC research and to identify factors associated
with enrollment and retention. Aim 2: To elucidate qualitative insights into modifiable and non-modifiable
factors impacting enrollment/retention in pediatric ECC research. Aim 3: To determine which factors are most
associated with successful enrollment of CRHDs. Aim 1 will be addressed through prospective tracking of
study enrollment/retention data in an anticipated 18 studies at a single site and factors associated with
enrollment. Aim 2 will be accomplished through semi-structured interviews of parents and study team staff. Aim
3 combines prospective survey and interview methods to develop a priority order for the most important factors
related to parental decisions to participate to plan future intervention studies.
This project will advance the candidate’s long-term goal to engage in interdisciplinary research and
policy development using evidence-based, stakeholder-informed, and ethically-sensitive practices to
reduce health disparities, address bias, and promote health equity for children. Mentors with expertise in
pediatric ethics, disparities, clinical trials, decision-making, and health communication augmented by essential
institutional support will permit the candidate to expand knowledge of research methods relevant to decision-
making, develop expertise in health disparities research, and cultivate dissemination and implementation
skills to effectively improve the evidence base relied upon to treat the sickest children. The proposed plan is
instrumental to a successful transition to independence and becoming a leader in the field.

Public health relevance
PROJECT NARRATIVE This proposal examines the extent to which children at risk for health disparities (CRHDs) are under- or over- represented in pediatric emergency and critical care research and identifies modifiable and potentially modifiable factors associated with enrollment of CRHDs. Results from this prospective mixed-methods study could lead to strategies that will reduce missed opportunities for enrollment across CRHDs and non-CRHDs, improving efficiency of NIH-funded research. Ensuring enrollment of CRHDs will also improve study validity and generalizability and further goals of equity and justice in healthcare by promoting equal research benefit for all.